CISAPRIDE IN TREATMENT OF CHILDREN WITH GI MOTILITY DISORDERS

To determine the safety and efficacy of oral Cisapride on the symptoms of gastrointestinal motility disorders and document any changes with long term treatment on antroduodenal motility and colonic motility/transit in children with GI motility disorders.